EFFECT OF CAFFEINATED BEVERAGES ON COLONIC EPITHELIAL CELLS

As caffeine can affect cell proliferation in vitro, this research examines the effect of dietary caffeine on the colonic epithelium. Subjects are given a well-controlled diet, with caffeine administered as an independent variable. Assessment of colonic epithelium, caffeine, and Ki-ras oncogene mutations are carried out before, during and after the caffeine introduction.